Sex and stress hormones control adrenal gland macrophage development and function"

Project Summary/Abstract:
Chronic stress promotes a systemic inflammatory response that contributes to cardiovascular and
metabolic disease (CVD), and even acutely augmented stress can exacerbate disease severity. In humans,
consumption of high fat/high cholesterol diet (HFD) is a common co-factor driving chronic stress responses.
Understanding mechanisms controlling the stress-response and its association with CVD diseases, which are
nearly ubiquitous and a leading cause of mortality, will allow for development of impactful translational
approaches to fight against this understudied disease. The AG is the primary source for steroid hormones,
corticosterone and aldosterone that are produced in the cortex. Elevated corticosterone modifies glucose
homeostasis, immunity, and tissue remodeling. Our prior work using a cold-temperature stress model showed
that cold-stress drives the promotion of monocyte egress from bone marrow and exacerbated atherosclerosis.
Therefore, we sought to determine whether the local immune cells in the AG were also responding to stress
responses, either through cold-exposure or HFD feeding. Interestingly, we observed accumulation of lipid within
AG resident macrophages sitting adjacent to hormone-producing endocrine cells in models of atherosclerosis,
hypertension, or acute cold challenge. Tissue resident macrophages are typically tissue repair cells and lipid
accumulation is associated with anti-inflammatory phenotypes in macrophages. AG macrophages have not been
thoroughly described in literature, and their function in response to hormone signals is unknown. Through our
preliminary studies of WT mice (chow-diet fed with no overt stressors), we identified two primary populations of
macrophages present in the AG. These populations showed a sexual dimorphism in the representation of
macrophage subsets when comparing adult male versus female mice. Furthermore, through single cell RNA-
seq profiling between male and female AG immune populations, we identified gene programs associated with
AG resident macrophages and found constitutive expression of the lipid-sensor Trem2, which was found to
increased on AG macrophages following chronic challenge, supporting a role in responding to lipid-hormones.
Loss of Trem2 was associated with lipid accumulation in the AG and elevated circulating corticosterone levels
in the absence of challenge. Together, these observations led to the overarching hypothesis AG resident
macrophage maintenance is controlled by sex hormone production, and that AG macrophages sense
steroid hormones during stress responses to dampen inflammation and promote tissue health. Our
extensive experience in studying tissue macrophage development and function, along with the utilization of new
animal models make our group ideal to test these novel concepts. If true, the implications of this study will identify
new approaches to regulate systemic inflammation responses through the modulation of AG associated
macrophages, which might complement current lipid-control approaches used for high-risk CVD patients.

Public health relevance
Project Narrative: Stress hormones are produced by the adrenal gland and promote systemic inflammation that contribute to cardiovascular and metabolic disease, which are two of the leading causes of morbidity and mortality worldwide. We will address sexual dimorphisms associated with adrenal macrophage development and their contribution to regulating the stress response following acute and chronic challenge models, and predict resident macrophages play a direct role in regulating this response. This study will provide definitive answers to adrenal macrophage ontogeny, onset of sexual dimorphism, heterogeneity, and responses to both acute and chronic stressors, knowledge that is essential for the development of therapeutic approaches to combat features of chronic stress that underlie high risk cardiovascular disease patients.